Translational Pulmonary Vascular Biology Program

PROJECT SUMMARY/ABSTRACT
The primary objective of this proposal is to continue our longstanding (45yr) cardiopulmonary research training
efforts at the University of Colorado Anschutz Medical Campus (CUAMC). This program trains individuals with
doctoral degrees in either biological or medical sciences for successful careers in research. A multidisciplinary
team-oriented approach to both mentoring and training emphasizing the integration of studies at the molecular,
cellular, tissue organ, and physiological (whole organism) levels permits rapid bench-to-bedside-to-bench
translation of the work performed. Our program is continually evolving. We expanded the focus to include access
to genomics and transcriptomics expertise through the Genomic Shared Resource Center and to advanced
computational skills through a new Center for Health Artificial Intelligence. These additions complement our
focus in Bioengineering, Biomaterials, Regenerative Medicine, Genomics, Metabolomics and Redox Biology.
Collectively, this expanded focus enables us to involve outstanding programs and investigators whose work
directly intersects with cardiopulmonary biology. Of the many training grants at CUAMC, this is the only one
specifically dedicated to pulmonary vascular biology and one of only 2 in the country focusing on this area. Our
continuing and long-term goal is that after 3 years of training the program’s fellows will have acquired the
professional skills to be competitive for research and/or teaching positions and obtain their own extramural funds.
Toward this end, we have added outstanding new scientific and educational mentors. Further, Dr. Flores has
been appointed multiple PI and brings great strength to our program as Vice Chair of Diversity and Justice for
the Department of Medicine. Our specific objectives are: 1)To attract and select talented and highly motivated
fellows who have a demonstrated interest in cardiovascular and pulmonary diseases. 2)To provide trainees with
an intensive research experience by pairing them with mentors who are rigorously selected based on their
qualifications. 3)To enhance the scientific knowledge and critical thinking abilities by requiring a series of formal
workshops/lectures. 4)To enhance multidisciplinary, collaborative approaches to research by requiring co-
mentors and a Team-oriented T-shaped Development for T-32 Trainees (T4) approach. 5)Train fellows in
responsible and ethical conduct of research. 6)To help the trainees/scientists develop proficiency with a wide
array of non-bench professional skills necessary for biomedical research careers such as communication,
leadership development, and project management and professionalism. 7)To introduce our fellows to a suite of
social science theories and provide instruction on how to navigate biases and microaggressions in academia.
The increasing national and international interest in pulmonary vascular biology, the expanded nature of our
program, and the excellent track record of training individuals from all backgrounds, including underrepresented
minorities, support our request for 6 postdoctoral trainees each year.

Public health relevance
PROJECT NARRATIVE A large number of human diseases can affect the structure and function of blood vessels in the lung. In fact, when diseases are complicated by increases in pressure in the lung blood vessels (lung vascular disease), significant increases in morbidity and mortality are observed, which are often due to dysfunction or failure of the right heart. This program is directed at training individuals to better understand the causes of lung vascular and right heart disease with the long-term goal that these investigators will develop new therapies to decrease or ameliorate the health burden of lung vascular problems.